PA22176, SBIR, Phase I, Mercato Thriving Communities Healthy Food Access Initiative

Abstract. Residents with a chronic lack of access to healthy food resources are at greater risk of being obese
and developing obesity related chronic diseases. These diseases include diabetes, several types of cancers,
cardiovascular disease, hypertension, and osteoarthritis which can decrease longevity and quality of life and
represent >10% of total health care expenditures annually. Unfortunately, while many groups have
recommended making changes to places where people shop for food to increase people’s ability and motivation
to purchase affordable and quality healthier food limited options exist. We seek to enable a ‘loop’ where people
have easy access to healthy, culturally appropriate foods, are able to easily redeem SNAP and other
public/private food benefits, jobs are created, grocers can remain in business and dollars circulate in local
communities. Our approach will be achieved with an existing eCommerce and local delivery platform that
provides thousands of independent grocers across the country with the technological tools to provide services
and a partnership with a local nonprofit with the experience and expertise in providing healthy foods to
underserved populations. Aims include (i) Prepare, educate, and enable independent grocers to provide and
deliver healthy food in underserved areas with a lack of access via multiple means of payment; and (ii) Enable
members of underserved populations the ability to easily access healthy food options online, make healthy
grocery purchases, and have these purchases delivered to their homes to improve healthy food access. This
project will provide a framework to be expanded and refined in Phase II to other neighborhoods to combat the
disparities of healthy food access and the associated negative health effects in underserved communities.

Public health relevance
Project Narrative Individuals living in lower-income communities, communities of color, or rural communities are less likely to have access to healthier foods leading to the development of obesity, chronic health conditions, and disparate health care outcomes. Here, in order to provide access to health foods in underserved communities a framework will be developed to both enable grocers to provide healthy food options and residents to purchase healthy foods from these retailers providing a health food access loop within local communities. By enabling healthy food access, this approach provides a framework to expand the program nationally to combat the disparities of healthy food access and the associated negative health effects in underserved areas.